DENERVATION, REJECTION AND IMMUNOSUPPRESSIVE THERAPY IN HEART/LUNG, LUNG TRANSPL

To evaluate the extent that complication factors effect long term survival. Areas of focus include immunosuppressive therapy, pulmonary allograft rejection, infection and pulmonary hypertension.